Research Training Program in Substance Abuse Prevention

Project Summary/Abstract
This renewal application requests continued support for the Postdoctoral Research Training Program in
Substance Abuse Prevention at Yale University. The host site for the program will continue to be the Division
of Prevention and Community Research in the Yale Department of Psychiatry, along with two primary partner
sites in Psychiatry: the Division of Addictions and the Yale Stress Center. In addition, the program will continue
to draw on faculty in three other Yale sites: Women's Health Research at Yale, the Yale School of Public
Health, and the Yale Child Study Center. Faculty have a strong track record of scholarship in substance abuse
prevention and longstanding collaborations as researchers and mentors. This application builds on the success
of our current training program originally funded by NIDA in 2005 and renewed in 2010 and 2015. Our request
for renewal funding is based on the continuing demand for advanced training in rigorous, interdisciplinary,
community-based translational research focused on substance abuse prevention. The program trains six
postdoctoral fellows across two years: 1) to understand drug abuse and addiction and related behaviors within
an ecological framework that emphasizes relevant developmental, family, social, cultural, and neurobiological
contexts; 2) to enhance knowledge in pre-intervention, implementation, and dissemination research; 3) to learn
state-of-the-art data analytic methods that incorporate rigorous field and laboratory research methods,
including mixed method designs; 4) to gain experience in interdisciplinary research through collaborations with
scientists working in interdisciplinary teams across departments, centers, and programs; and 5) to increase
knowledge about the translation of research into real-world contexts in order to impact prevention practice and
policy, and ultimately, public health. These program objectives are reinforced in mentored relationships with
two scientific advisors, didactic seminars, and individually-tailored experiences based on each fellow’s
Individual Development Plan. The training aligns with NIDA research objectives and cross-cutting priorities.
Over the past 14 years, the program has enrolled 38 fellows, who have virtually gone on to careers as
prevention scientists. More than three-quarters are faculty in academic settings, and others are employed as
prevention scientists in interdisciplinary research organizations. The program has also been successful in
training fellows from diverse backgrounds; 26% identify as an underrepresented racial/ethnic minority and 13%
identify as other racial/ethnic minorities.

Public health relevance
Project Narrative This program offers postdoctoral research training in substance abuse prevention to generate knowledge about the translation of research into real-world settings in order to impact prevention practice and policy, and ultimately, public health. The training provided aligns very well with NIDA strategic research objectives and priorities. Also, since the program's inception, it has been very successful in training fellows from diverse backgrounds as prevention scientists.